Regulation and function of the Hippo pathway in growth control

PROJECT SUMMARY
The Hippo pathway is a key regulator of development, regeneration, tissue homeostasis and organ size,
whose dysregulations have been frequently observed in human diseases like cancer. In mammals, the Hippo
pathway is composed of a core kinase cascade that comprises two Ser/Thr kinases MST and LATS as well as
their adaptor proteins SAV1 and MOB1, respectively, downstream effector protein YAP, and nuclear
transcription factor TEAD. Upon Hippo pathway activation, MST phosphorylates and activates LATS, which in
turn phosphorylates YAP, resulting in its cytoplasmic retention and degradation. Un-phosphorylated YAP is
translocated into the nucleus, where it binds TEAD to drive the transcription of genes involved in various
growth-related events. Recent studies in both Drosophila and mammals have further revealed MAP4K-family
kinases (MAP4Ks) and PP2A phosphatase complex STRIPAK as additional components of the Hippo
pathway, where MAP4Ks act in parallel to MST to phosphorylate and activate LATS, while STRIPAK inhibits
MST and MAP4Ks to control the Hippo core kinase cascade. Multiple growth-related signaling events, such as
growth factors, glucose/energy homeostasis, cell-cell contact, mechanical cues and a series of stress signals,
have been uncovered to regulate the Hippo pathway and its downstream YAP-dependent transcriptional
program. However, precisely how these upstream signaling stimuli feed into the Hippo pathway core
components has not been fully understood. In the past grant period, we shed light on this long-standing
question by characterizing phosphatidic acid and its-associated lipid metabolic pathway in transducing the
Hippo pathway upstream signaling events to the Hippo pathway kinase LATS. In the current grant period, we
propose to re-examine the Hippo pathway in energy stress response that was discovered by us a few years
ago. Specifically, we will elucidate the molecular mechanisms underlying the energy stress-induced Hippo
pathway activation by characterizing the role of the AMPK-STRIPAK-MAP4Ks axis in this process (Aim 1). In
addition, we will investigate a YAP-independent function of the Hippo pathway in promoting cell survival
against energy stress (Aim 2). Collectively, completion of this project will reveal mechanistically how energy
stress activates the Hippo pathway and provide functional insights into the Hippo pathway in growth control
and cancer development.

Public health relevance
PROJECT NARRATIVE The Hippo pathway plays crucial roles in various physiological processes and is frequently altered in cancer development. The overall goal of this R01 proposal is to elucidate the regulation and function of the Hippo pathway in growth control and tissue homeostasis. Completion of this project will enrich our understanding of the Hippo pathway in normal physiology and lay the molecular foundation for developing new therapeutic strategies for cancer treatment.